MODIFICATION OF DIET IN RENAL DISEASE STUDY

The protocol for the MDRD Study has been written and we will adhere to these instructions throughout the study. This application is directed at demonstrating that the Emory University Renal Division can provide the following items necessary or participating in the MDRD Study, A) Knowledgeable, experienced staff to perform the trial; B) Potential patients who could be enrolled in Study A (early renal insufficiency) and Study B (moderate renal insufficiency); C) A recruitment plan for enrolling 40-45 patients in the trial; D) Sufficient space and University support to complete the MDRD Study.